Leica tauSTED super resolution microscopy for molecular imaging in fixed and live specimens

Project Summary
Super-Resolution Fluorescence Microscopy (SRFM) has become an indispensable tool for
scientists to probe discrete molecular proximities. Currently, systems in the Keck Center at the
University of Virginia can only reach resolutions of ≥120 nm; to break that barrier for fixed or live cells,
Leica STELLARIS 8 tauSTED microscopy can achieve ~30-50 nm resolution for fixed specimens. As a
research and teaching institution in the highly competitive academic environment, it is essential to make
these advanced technologies available for the biomedical sciences. A second driver for this application
is the need to replace the existing and non-repairable 14-year-old Leica SP5x confocal microscopy
system, purchased through the S10 program in 2007. The requested super-resolution tauSTED
microscopy system will answer both needs and will benefit the basic and clinical sciences of this
university; in particular, the 12 participating federally funded investigators (9 major and 3 minor users)
of the Keck Center (KCCI). The higher quantum efficiency HyD (46%) and the new photon detection
efficiency (PDE) detector (58%) provides a better option to excite the sample with less excitation
intensity and detecting weaker photon levels in cells and tissues. This instrument is essential for our
core investigator group to investigate the subcellular architecture and cell dynamics at nanoscale
dimensions and will also be critical for training other investigators and students attending the fall
semester microscopy course interested in the study of various biological applications including
developmental, neuroscience and cell biology.
The requested system will be housed in the internationally recognized W.M. Keck Center for
Cellular Imaging (KCCI), which is particularly known for its advanced microscopy and molecular
imaging. KCCI is a university-wide imaging facility, located within walking distance of all participating
investigators from the School of Arts & Sciences, Engineering, and Medicine. KCCI is also recognized
for its annual hands-on training FLIM & FRET workshop, held for the past 19 years at the University of
Virginia. The requested super resolution tauSTED microscopy is an advanced technology, which will be
housed in the Leica SP5x room (11'x14') and configured appropriately to meet the experimental
conditions of users in this proposal and additional existing and future users of the KCCI imaging core.
In summary, the requested instrument will provide the research community at the University of
Virginia and beyond with a level of imaging capability that is not currently available and will enhance
significantly ongoing and future research.

Public health relevance
Project Narrative Super-resolution microscopy is essential for our core investigator groups to study the subcellular architecture and cell dynamics at nanoscale ranges and stay competitive in this fast-expanding section of light microscopy. It will also be critical to train other investigators and students attending the fall semester microscopy course interested in the study of various biological applications including developmental, neuroscience and cell biology. If we have to understand disease processes and design therapeutic strategies, it is important to develop super-resolution live-cell imaging technologies with the Leica tauSTED microscope, which represents a substantial advance in the light microscopy imaging area.